Photoacoustic Image Guidance of Hysterectomies

Project Summary
Ureteral injury represents one of the most serious complications of pelvic surgery, with a majority of these
injuries occurring during gynecological procedures. This injury is particularly problematic during hysterectomies
because of the proximity between the ureter and nearby blood vessels. One barrier to progress is the absence
of clinically available technology to identify relative positions of the ureter, uterine arteries, and tool tips with suf-
ficient depth penetration and image contrast. We previously demonstrated that photoacoustic imaging achieves
simultaneous detection of critical structures with approximately 25-30 dB contrast at centimeter depths, allowing
for complete avoidance of the ureter and better targeting of the uterine arteries. However, to advance this tech-
nology into surgical practice, we need to establish the optical, acoustic, and navigation parameters necessary
to achieve optimal detection of tool tips, blood vessels, and ureters. Optimizing photoacoustic imaging system
designs and providing informative real-time feedback during hysterectomies will enable these surgeries to be
performed without the complications that are typically associated with ureteral injuries, including extensive re-
peat surgeries, complete kidney failure, sepsis, acute renal insufficiency, and patient death. Our long-term goal
is to develop guidance technology to differentiate critical structures in real-time during surgery.
The overall objective of this proposal is to establish optimal parameters to advance photoacoustic technol-
ogy toward differentiation of ureters, uterine arteries, and tool tips during hysterectomies. Aim 1 of this project
will define the light delivery requirements for optimal visibility of laparoscopic surgical tool tips and underlying
structures. Aim 2 will integrate and optimize sound reception components and parameters for photoacoustic
imaging of the ureter, uterine artery, and tool tips. Aim 3 will pursue in vivo demonstrations of robotic hysterec-
tomy navigation with photoacoustic imaging system components. These three aims will be tested independently
with a combination of simulation, cadaver, swine, and human patient studies, resulting in multiple possibilities for
deploying the proposed technology.
Successful completion of the proposed project will establish a series of viable photoacoustic imag-
ing system designs to enable ureter avoidance during hysterectomies. This project is innovative because
of the novel integration and refinement of photoacoustic approaches and techniques to distinguish the ureter
from the uterine artery. The project results are anticipated to have a significant impact on patients undergoing
laparoscopic hysterectomies, robotic hysterectomies, and other robotic surgeries (e.g., radical prostatectomies,
thoracic surgeries), with possible extensions to additional surgeries wherein critical structures reside in close
proximity. The proposed research aligns with NIBIB’s mission to accelerate the application of biomedical tech-
nologies by supporting research to advance the development of new tools for visualizing critical structures to
target or avoid during minimally invasive surgeries.

Public health relevance
Project Narrative This project is relevant to public health because hysterectomies (i.e., surgical removal of the uterus) are a common surgical procedure performed in women over the age of 60. Ureteral injuries are a serious complication of hysterectomies due to poor visualization of the ureter (which needs to remain intact to preserve urinary func- tion) and nearby blood vessels (which need to be severed for uterus removal). Our aim is to establish a novel photoacoustic imaging technology that will enable surgeons to avoid the ureter and better target the uterine arteries while detecting surgical tool tips to mitigate a serious complication of hysterectomies.